Pericardial mRNA therapy for myocardial infarction

PROJECT SUMMARY
Heart disease is the leading cause of death in the US. Myocardial infarction (MI) causes more than
557,650 deaths per year in the US. Inflammation is key to determine the MI outcomes. Chronic inflammation
may lead to poor outcomes. Anti-inflammation treatment can improve the outcome. Stem cell derivates are well
known anti-inflammation agents. Yet the use of stem cell derivates is hindered by safety concerns and elusive
mechanism. So it is important to develop a drug that is safe and effective and is with known mechanisms. In
this study, we will develop a new anti-inflammation drug. The drug is developed based on our previous
mechanistic studies on stem cell derivates for heart repair. Safety and effectiveness of the drug will be studied
in mouse and patient relevant pig models of MI. This drug will be injected into the pericardial space via a
minimally invasive intrapericardial (iPC) injection procedure. This drug will be administrated immediately or 3
days after MI modeling. The animals will be followed up to 4-12 weeks after treatment. Heart function and
morphology will be evaluated to determine therapeutic efficacy. Success in this study will pave groundwork for
future IND application.

Public health relevance
PROJECT NARRATIVE Management of post-MI inflammation is crucial for improving patient outcomes in clinics. Based on our preliminary mechanistic studies on stem cell exosomes for myocardial infarction, in this proposal, we seek to develop a pericardial delivered lipid nanoparticle-based mRNA therapy for anti-inflammation and heart repair in mouse and clinically relevant pig models.